Developmental Research Program

Developmental Research Program - Abstract
The UNC Breast Cancer SPORE Developmental Research Program (DRP) has promoted novel breast cancer research across the population, translational, and clinical arenas since 1992. This highly successful Program includes mechanisms for stimulating grant applications, rigorously evaluating proposals, selecting projects with advocate input, and monitoring progress. Application mechanisms include both regular competitive awards as well as rapidly emerging opportunities. Evaluation and selection processes include a well-established, independent scientific peer review that includes patient advocates. The SPORE Multi-PIs Perou and Carey, with input from the Executive Committee, make final decisions regarding selection and budget. We expanded formal solicitation to other UNC system universities to continue to grow the faculty with the most innovative ideas to improve breast cancer prevention, early detection, therapy and survivorship care. The program has increased in the past decade with increased institutional commitment to expanded faculty recruitment. The process will feature a robust twice-yearly solicitation for competitive DRP awards across UNC and our sister UNC System universities. UNC Lineberger’s commitment to the Breast SPORE goes beyond this, with the Multi-PIs and Cancer Center investing directly in major programs (e.g., CBCS Phase 4), infrastructures (tripling of the size of the cellular therapy GMP facility) and technology (a NovaSeq X and CosMx purchase). The Multi-PIs co-conceptualize the emerging investments with the needs of both innovative science and the CEP recruits in mind.

Public health relevance
The UNC Breast Cancer SPORE Developmental Research Program (DRP) has promoted novel breast cancer research across the population, translational, and clinical arenas since 1992. This highly successful program includes mechanisms for stimulating grant applications, rigorously evaluating proposals, selecting projects with advocate input, and monitoring progress. Shelton Earp, MD, who has led this program since its inception in 1992 will continue to oversee the DRP process and evaluation with administrative help from David Darr, MBA, MSc, LCCC Associate Director for Administration, and Michele Hayward, RD, ACRP-CP SPORE Administrator. Application mechanisms include both regular competitive awards as well as rapidly emerging opportunities. Evaluation and selection processes include a well-established, independent scientific peer review that includes patient advocates. The SPORE Multi-PIs Perou and Carey, with input from the Executive Committee, make final decisions regarding selection and budget. During the last cycle, we expanded formal solicitation to other UNC system universities to continue to grow the faculty with the most innovative ideas to improve breast cancer prevention, early detection, therapy and survivorship care. The program has grown in the past decade with increased institutional commitment to expand faculty recruitment. In this next year, this commitment will total $225,000 yearly. The process will feature a robust twice-yearly solicitation for competitive DRP awards across UNC and our sister UNC System universities. UNC Lineberger’s commitment to the Breast SPORE goes beyond this, with the Multi-PIs and Cancer Center investing directly in major programs (e.g., CBCS Phase 4), infrastructures (tripling of the size of the cellular therapy GMP facility) and technology (a new NovaSeq X and a recent CosMx purchase). The Multi-PIs co-conceptualize the emerging investments with the needs of both innovative science and the CEP recruits in mind. Since the last renewal, the program has funded thirty projects, initiating two renewal full SPORE projects as well as seeding preliminary research yielding extramural funding from non-SPORE sources and important publications. In this past year we have supported new projects and both DRP and CEP recruits. Two major DRP projects were initiated in Year 1 of the current cycle using the well-functioning process followed by approval from the Multi-PIs.